Task A82: Murine Models of UTI Caused by Antibiotic-Resistant Bacteria

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.